Mass General Brigham Training Program in Precision and Genomic Medicine

This application is for a renewal of the Mass General Brigham (MGB) Training Program in Precision & Genomic
Medicine, which began in 2019 and is designed to provide rigorous, interdisciplinary training of postdoctoral
scientists in the translational genomic, clinical and computational sciences that are driving a new era of precision
and genomic medicine. Our proposal brings together three outstanding components to build a world-class
training program genomic medicine: 1) an internationally-recognized faculty of experienced mentors with
expertise in precision and genomic medicine across a broad range of disciplines, 2) outstanding institutional
resources bridging clinical, genomic, and data sciences, and 3) deep engagement with cutting edge,
collaborative initiatives at the regional, national, and international levels to provide rich training experiences. The
program has a particular emphasis in four domains of precision and genomic medicine in which the participating
institutions and faculty have become national and international leaders: 1) medical genetics and genomics; 2)
data science; 3) molecular medicine; and 4) implementation science. A core element of the training program is
a mentored research experience that includes mentored research projects and career development guidance.
We have assembled a group of 55 established and highly collaborative faculty mentors across the Mass General
Brigham Healthcare System (including Massachusetts General Hospital and Brigham and Women’s Hospital)
as well as Harvard Medical School, MIT, the Broad Institute, and Boston Children’s Hospital). The program also
provides a structured but flexible curriculum of didactic courses, journal clubs, and seminars covering scientific
foundations, essential skills for career development, team science, and RCR training. Trainees work closely with
a mentorship team comprising a Primary Mentor, a Secondary Mentor (providing complementary experience or
collaboration opportunities to their primary research focus), and the two Program Directors. An individualized
training program will be developed and monitored in conjunction with the mentorship team. Trainees also benefit
from access to extensive data networks and resources in which our faculty have played leading roles including
the eMERGE network, TOPMed, the All of Us Research Program, ClinGen, the MGB Biobank, gnomAD, the
Center for Mendelian Genomics, the Undiagnosed Diseases Network, and others. We have established new
partnerships to enhance the recruitment and retention of trainees from underrepresented backgrounds. Program
oversight will include guidance from a Steering Committee of senior faculty mentors and an External Advisory
Board of nationally-renowned leaders spanning the four domains of precision and genomic medicine research.
As in our past cycle, the program is geared toward physician-scientists as well as PhD or equivalent scientists
intending to develop careers in precision or genomic medicine research. Trainees are supported for two years
and the program will accept three new fellows annually for a total of six fellows in the program each year. At the
completion of this fellowship, trainees will be well-prepared to launch independent research careers in genomic
medicine.

Public health relevance
The rapidly developing field of precision and genomic medicine offers enormous opportunities to transform research and clinical practice. This postdoctoral training program brings together three outstanding components to build a world-class training program in genomic medicine: 1) an internationally-recognized faculty of experienced mentors with expertise in precision and genomic medicine, 2) outstanding institutional resources bridging clinical, genomic, and data sciences, and 3) deep engagement with cutting edge, collaborative initiatives at the regional, national, and international levels to provide rich training experiences. Our goal is to provide rigorous, multidisciplinary training for a new generation of scientific leaders who can drive progress in the field.